Molecular Drivers of Atherosclerosis in Diabetes

PROJECT SUMMARY
The mortality rate among individuals with type 1 diabetes (T1D) remains significantly elevated due to
cardiovascular complications, highlighting a critical need for innovative research focused on understanding and
mitigating cardiovascular disease (CVD) in this population. Unlike type 2 diabetes (T2D), T1D presents a
unique trajectory of CVD progression, with persistently elevated risk factors that are not fully explained by
conventional cardiovascular risk assessments. Emerging evidence suggests that T1D's autoimmune nature
may contribute to CVD through inflammatory pathways, yet this area remains underexplored. This grant
proposal aims to elucidate the molecular and cellular mechanisms underlying the increased CVD risk in T1D
compared to T2D and non-diabetic individuals. Leveraging an interdisciplinary team with a strong track record
of collaboration and expertise in T1D, CVD genetics, single-cell technologies, and disease modeling, we
propose a comprehensive study that builds on preliminary findings indicating distinct genetic and molecular
drivers of atherosclerosis in diabetic patients. In aim 1 of this proposal, we will delineate the differential
immune profiles in T1D, T2D, and non-diabetic individuals by analyzing serum proteins and immune cell
characteristics. In aim 2, we will identify cellular and molecular differences in atherosclerotic plaques across
these groups, focusing on variations in plaque composition, cell-cell communication, and regulatory networks.
And in aim 3, we will validate the key regulators of atherosclerosis-relevant phenotypic changes in diabetic
states through functional experiments. The outcomes of this study are expected to provide unprecedented
insights into the immune-mediated mechanisms of CVD in T1D, leading to the identification of novel molecular
targets for therapeutic intervention. To maximize the impact of our findings, we will create a user-friendly
website to share our comprehensive -omics datasets with the broader research community, fostering further
discovery and collaboration.

Public health relevance
PROJECT NARRATIVE Our research investigates why type 1 diabetes significantly raises heart disease risk. Unlike type 2 diabetes, type 1 involves unique cardiovascular complications not fully explained by usual risk factors. We suspect that diabetes-related immune system irregularities contribute to heart issues. By analyzing immune and heart tissue differences in diabetic versus non-diabetic individuals, we aim to pinpoint these immune interactions' role in heart disease, potentially leading to new treatments that can lower heart disease risk in diabetes patients.